Cathelicidin in Skin Immunity

PROJECT SUMMARY (See instructions):
This project has sought to understand the functions of the cathelicidin family of antimicrobial peptides in
mammalian immunity. Cathelicidins are an evolutionarily conserved gene family, with orthologous genes
present in several species. Conservation between family members resides primarily in the amino-terminal
precursor domain. The carboxy-terminal peptide domain has potent immunological activity, acting as an
endogenous direct antimicrobial that kills some pathogens. Our previous work has shown that this activity
is essential for resistance to invasive bacterial infection by S. aureus and Group A Streptococcus and
associated with several human inflammatory diseases. However, our group and others have found that
some of the human disease associations with cathelicidin are likely not a consequence of its antibiotic
activity but rather due to its immune activating activity. Several important observations prior to year 1
suggested that the human cathelicidin peptide LL37 will amplify inflammation by presenting nucleic acids
to cytosolic receptors. We termed this process " innate immune vetting " .

Public health relevance
RELEVANCE (See instructions): Cathelicidin is a type of antimicrobial peptide known to be important to human disease since infection occurs when expression of this peptide is insufficient, and inflammation occurs when cathelicidin is too abundant. This project builds on a breakthrough discovery into the mechanism of action of cathelicidin to promote inflammation. Our approach seeks to better understand this process and explore potential strategies that can be exploited to treat disease.